Linking stress-associated brain and adipose functions

PROJECT SUMMARY/ABSTRACT
The fundamental mechanisms by which acute intense stress affects energy homeostasis via brain substrates
and sexual dimorphism of these processes are poorly understood. Environmental stressors induce fight-or-
flight-or-freeze response via the locus coeruleus (LC) in the brainstem, a major sympathetic regulator in
humans and animals that triggers energy metabolism. LC innervates the brown adipose tissue (BAT) and
expresses high levels of PAC1 receptor for the neuropeptide PACAP (pituitary adenylate cyclase activating
peptide). PACAP/PAC1 are critical regulators of stressors of all kinds, fear, appetite, feeding, and energy
metabolism and genetically linked to stress-related disorders like post-traumatic stress (PTSD) in humans.
Intriguingly, women with PTSD showing high blood levels of this neuropeptide and brain PAC1 receptors
regulate fear in a sexually dimorphic manner in animals. To test the importance of PAC1 in acute intense
stress and energy homeostasis, we used the stress-enhanced fear learning (SEFL) behavioral model in mice.
Our preliminary data show that ablation of PAC1 receptors from the LC enhances SEFL expression, energy
metabolism as assessed by indirect calorimetry measurement, and increases metabolic genes like uncoupling
protein 1 in BAT in females than males. Thus, harnessing on the biology of PAC1 receptors, we aim to lay a
mechanistic framework linking acute intense stress and energy metabolism in a systematic and sex-dependent
manner via the LC. We hypothesize that PAC1 receptors in the LC are important for gating stress-associated
metabolic information and BAT functions in a sexually dimorphic manner. Aim 1 will test a SEFL mediated loss
of function of LC-PAC1 on whole body energy expenditure and on BAT functions. For this, we will test if viral
cre-recombinase mediated PAC1 deletion from LC in mice with floxed PAC1 regulates SEFL-associated
energy expenditure and induction of thermogenic genes in BAT in a sex-dependent manner (via transcript
analysis, mitochondrial bioenergetics, and tissue lipolysis). Aim 2 will test if PAC1 expressing LC neurons
project directly to BAT in a sexually dimorphic manner under SEFL. For this, we will use retrograde viral tracing
to determine LC to BAT projecting cell populations combined with in situ hybridization for PAC1 in LC. We
predict that female mice will show enhanced energy expenditure, BAT thermogenesis and increased LC
projection to BAT. Overall, using state-of-the-art tools and techniques and rigorous systems biology approach
of linking acute intense stress and energy metabolism, our studies will lay crucial groundwork for several future
work. This will serve as a premise for studying central sympathetic control of metabolism in chronic stress-
related conditions such as PTSD that are comorbid with metabolic diseases and increasingly prevalent in the
US populations.

Public health relevance
PROJECT NARRATIVE Acute are by information comorbid stressors affect energy homeostasis via brain and body interactions. The proposed experiments designed to identify key changes in energy metabolism in male and female mice after acute stressor manipulating a key central nervous system region that drives stress-related behaviors. This basic is critical for developing novel strategies to treat stress-associated conditions that are with energy dysregulation.